MOLECULAR PATHOLOGY

The purpose of Core C is to provide the following supportive services for individual projects: 1) Centralized pathology review of all human tissues obtained. 2) Preparation and utilization of formalin-fixed, paraffin embedded human tissues. 3) Construction of tissue microarrays. 4) Provision of immunohistochemistry, fluorescence in situ hybridization, and other similar tools for analyzing human tissues obtained. Core C will be directed by Dr. Joseph Khoury who is a board-certified pathologist at St. Jude Children's Research Hospital